Characterize TMEM94 as ER Mg2+ uptake machinery and pathophysiological consequences.

ABSTRACT
The intracellular Mg2+ (iMg2+) has essential roles as a counterion for negative charges, stabilizer of molecular
and macromolecular structures, and cofactor for many enzymatic reactions in living cells. In eukaryotes, Mg2+ is
the most abundant divalent cation essential for cellular functions and its perturbation is associated with several
clinical conditions including migraines, obesity, diabetes, cardiovascular diseases, and preeclampsia however,
the molecular events that directly link Mg2+ to cardiovascular disease progression are still elusive. Although the
consensus is that free ionized intracellular Mg2+ (iMg2+) is bound with phosphometabolites, nucleic acids and
proteins (17-30 mM), molecular mechanisms that control free iMg2+ (~0.5-1.2 mM) compartmentalization is
limited. Fluctuations in free cytosolic Mg2+ (cMg2+) following stimulation have been touted as passive adjustments
of Mg2+ dissociating from the exuberant Mg-ATP and other buffered pools. Our recent identification of small
ligand-like activators opened a new avenue to understand the iMg2+ dynamics and the cause-effect relationships
that exist between iMg2+ flux and cellular processes (Cell 2020). Having proved L-lactate as a ligand for ER Mg2+
(ERMg2+) dynamics, we asked whether the iMg2+ is compartmentalized and the existence of Mg2+ transporters
across the subcellular membranes. Our recent discovery revealed that ER/SR is the primary site for iMg2+ store
that is refilled by ER localized P-type Mg2+ ATPase (ERMA) (Molecular Cell 2024). Although ERMA is
discovered as an ER localized P-type Mg2+ ATPase, it is unknown whether ERMA is localized in the SR
membrane as an integral protein in cardiomyocytes. The highly conserved ERMA is exclusively localized on the
ER/SR membrane with a Mg2+ binding signature motif. Remarkably, ERMA human mutations manifest
neurodevelopmental disorders, congenital heart malformations, and facial dysmorphism. To explore the
functional role of ERMA in cardiac cell types, we conducted the expression, localization and measured the activity
of ERMA in adult cardiomyocytes. Our finding show that ER/SR is the primary reservoir for free Mg2+ ions in
most cell types including cardiomyocytes. Based on this finding, we hypothesize that ERMA is a major Mg2+
transporting P-ATPase responsible for the uptake of cMg2+ into the ER/SR. Our three specific aims will:1.
Establish ERMA-mediated SRMg2+ uptake in cardiomyocytes. 2. Determine the conserved domains, post-
translational modification of ERMA that are crucial for SR/ERMg2+ uptake. Additionally, we will determine the
structure function of ERMA and its oligomeric nature for the activity, and 3. Discover the physiology and
pathogenesis associated with ERMA mutations in cardiac myocytes and cardiac function in vivo. The outcomes
of this study will highlight potential new therapeutic targets for the treatment of conditions associated with cardiac
diseases.

Public health relevance
NARRATIVE The original premise was that the cellular Mg2+ is mostly bound with cellular metabolites, nucleic acids, and proteins with an equilibrium of one between cytosol and subcellular compartments. Although aberration of Mg2+ homeostasis is associated with several clinical conditions, very little is known about the molecular details of Mg2+ transport into/from cellular organelles like the sarco-endoplasmic reticulum and the proposed studies will reveal a previously unexplored role of ERMA in intracellular Mg2+ dynamics to key cardiac function, which may offer new therapeutic approaches for the treatment of heart diseases.